Neural mechanisms underlying the connection between Neurotrauma and REM Sleep Behavior Disorder

Neurotrauma, including traumatic brain injury (TBI) and/or posttraumatic stress disorder (PTSD), is highly
prevalent among US Veterans returning from military deployment, approximating upwards of 10-20% from
recent conflicts in the Middle East. In addition to a myriad of disabling daytime symptoms, we and others have
shown that neurotrauma is strongly associated with persistent and profound sleep disruption, in some cases
lasting for decades. In particular, emerging evidence suggests that neurotrauma may disrupt normal inhibition
of muscle tone during sleep. During rapid eye movement (REM) sleep, widespread paralysis of skeletal
muscles normally occurs – a process that is dysregulated in REM sleep behavior disorder (RBD),
characterized by violent dream enactment during REM sleep. We recently reported that RBD is increased by
over two-fold in Veterans with comorbid TBI+PTSD, compared to Veterans without neurotrauma. The
abnormal REM Sleep Without Atonia (RSWA) seen in patients with RBD is widely regarded as one of the
earliest clinical manifestations of synucleinopathy, since 50-70% of patients with RBD eventually phenoconvert
to Parkinson's Disease (PD) or related disorder. Emerging evidence from several epidemiological studies,
including our own, have suggested that both TBI and PTSD synergize to increase risk of later development of
PD. However, major gaps in our understanding remain. We still need to better understand the predictors and
neural pathways by which neurotrauma leads to RBD and synucleinopathy among susceptible individuals, and
we need to identify candidate therapies and windows for potential neuroprotective interventions in order to
prevent phenoconversion. These gaps will be addressed in 3 aims. Aim 1 will determine the behavioral
correlates of RSWA using a mouse model of combined TBI+PTSD. Using our previously established model of
combined TBI+PTSD, mice will undergo controlled cortical impact and single prolonged stress procedures,
followed by gait analysis, fear conditioning, and sleep electroencephalographic (EEG)/ electromyographic
(EMG) recordings to quantify RSWA. Mice will then be segregated into 3 groups on the basis of trauma
exposure and behavioral severity: Neurotrauma (NT), Trauma-Exposed (TE - behaviorally normal), and
Controls (not exposed to trauma). In Aim 1, we hypothesize that mice in the NT group will show increased
RSWA compared to TE and Controls, and the severity of behavioral symptoms will predict the degree of
RSWA within the NT group. In Aim 2, we will determine brain functional connectivity underlying RSWA and
behavioral deficits in mice with TBI+PTSD by using an innovative new method to image cerebral blood flow in
live animals with functional ultrafast ultrasound (fUS). We hypothesize that mice in the NT group will show
increased functional connectivity within the amygdala that will correlate with readouts of both behavior and
RSWA. In Aim 3, we will determine how neurotrauma contributes to RSWA and synuclein dynamics in the
SynGFP transgenic mouse, and test the ability of curcumin to slow this process. We will use the A53T SynGFP
mouse, an established mouse model of accelerated synucleinopathy that closely mimics the human condition,
in combination with our methods for TBI+PTSD and sleep recordings. We hypothesize that neurotrauma will
accelerate alpha-synuclein deposition, and that curcumin will decrease alpha-synuclein burden and ameliorate
behavioral deficits among NT mice. Results from these studies will provide valuable mechanistic information
about the pathophysiology underlying neurotrauma's effects on REM sleep and synucleinopathy, as well as
test a potentially promising treatment intervention. With this critical knowledge, we will take important steps
forward in better predicting and mitigating potential neurodegeneration among Veterans with TBI/PTSD.

Public health relevance
Neurotrauma, such as traumatic brain injury (TBI) and posttraumatic stress disorder (PTSD), can cause persistent and profound sleep disruption, including abnormally increased muscle tone during rapid eye movement (REM) sleep, or REM sleep behavior disorder (RBD). While RBD has been associated with early synucleinopathy and parkinsonism, the specific predictors and neural pathways by which neurotrauma leads to RBD and synucleinopathy are unknown. We aim to address these gaps using our mouse model of neurotrauma that shows REM sleep abnormalities, in combination with a transgenic mouse model of Parkinson's Disease, as well as test the ability of the botanical curcumin to mitigate synucleinopathy. Results from these studies will provide valuable mechanistic information about the pathophysiology underlying neurotrauma's effects on REM sleep and synucleinopathy. With this critical knowledge, we will take important steps forward in better predicting and mitigating potential neurodegeneration among Veterans with TBI/PTSD.